AWARE Project 1: Impact of unhealthy alcohol use, HIV reservoirs, and social disadvantage on candidate biomarkers of inflammaging

AWARE PROJECT 1 (BIOMARKERS)
The concept of inflammaging brings together biological phenomena accentuated in people aging with HIV (i.e.,
chronic inflammation, immune dysfunction, comorbid disease). The Alcohol Harm Paradox (see Overall grant)
suggest that those living in socio-economically disadvantaged communities may experience more
inflammaging than those without these exposures. Our goal is to better understand the biology underpinning
how exposure to unhealthy alcohol use and socio-economically disadvantaged communities contribute to
inflammaging in the context of HIV infection. We propose a novel operationalization of inflammaging relevant to
people with HIV comprising biological age acceleration, HIV reservoir size, and embodied social adversity. Our
approach recognizes and seeks to describe the multiple, interacting, biological effects of these complex
exposures. We anticipate that the findings will provide biological insights on inflammaging that may help tailor
future interventions to promote healthier aging in people with HIV (PWH). Biological age acceleration, occurs
when the rate of biological aging exceeds that of chronological aging and is associated with morbidity and
mortality. No established biological age estimator (clock) targets inflammaging. Aim 1 will determine the
association of unhealthy alcohol use and biological (multi-omic) age acceleration including biological aging
estimated using a novel inflammation-derived clock. HIV latency and resulting persistence in cellular
reservoirs drives and is driven by inflammation and immune activation and are the major obstacles to curing
HIV. Yet, despite known immunomodulatory effects of alcohol, the relationship of alcohol and HIV reservoir
size has not been studied. Aim 2 will determine the association of A) alcohol use and HIV reservoir size in
CD4+ T-cells; and B) HIV reservoir size and biological age acceleration in people with HIV. Conserved
Transcriptional Response to Adversity (CTRA) expression is a pattern of dysregulated
immunologic/inflammatory gene expression profiles observed in those with extended exposures to adverse
environmental conditions (e.g., poverty, chronic stress). How alcohol use alters CTRA expression is poorly
understood generally and in the context of HIV. Aim 3 will explore A) the association of alcohol use and CTRA
expression; B) the correlates of CTRA expression in PWH including socioeconomic deprivation; and C)
association of CTRA and biological age acceleration. Our work paves the way for future mechanistic studies
explaining how unhealthy alcohol use causes negative health consequences among PWH. This body of work
will also identify novel biomarkers of inflammaging relevant in future alcohol intervention studies in the context
of HIV.